Single Nucleus Transcriptional Profiling of Intractable Focal Epilepsy

PROJECT ABSTRACT
Up to 30% of individuals with epilepsy have intractable seizures. It is unclear how mechanisms underlying seizure
onset and propagation operate regionally in intractable focal epilepsy, in which tissue involvement is
heterogeneous and regions play different roles in seizure initiation, propagation and resistance to spread. Better
understanding is needed of the biology underlying the seizure focus versus the penumbra, where excitatory
discharges appear on EEG but neuronal response is limited by intact inhibition. Imbalance of inhibitory and
excitatory neuronal inputs (I/E imbalance) is a primary factor underlying seizure generation and propagation,
particularly interneuron dysfunction and interneuron/pyramidal cell interaction. I/E imbalance influences seizure
generation in a wide array of epilepsy pathologies; investigation of I/E imbalance and interneuron function can
thereby reveal pathways common to many types and causes of epilepsy. We hypothesize that cell-type specific
alterations result in I/E imbalance in brain resected during surgery for intractable focal epilepsy, and that these
transcriptional changes will correlate with histopathology and regional EEG. We will test this by performing single
nucleus RNA sequencing (snRNAseq) on MRI-guided electrophysiologically-localized biopsies from patients
undergoing epilepsy surgery. This will provide site-specific correlation of cell type-specific transcriptomic profiles
with histological, radiographic, and electrophysiologic alterations. We will sample the seizure focus and
penumbra to determine the differences in cellular composition and cell type-specific expression profiles, and
identify alterations involved in seizure generation and propagation. Although we will focus on interneuron
profiling and I/E imbalance, snRNAseq will provide data on the diversity of cell types. In AIM 1 we will use
snRNAseq to identify differential expression of genes in seizure focus vs. penumbra in human brain resected
during surgery for intractable focal epilepsy, focusing on interneuron vs excitatory pyramidal cell transcriptional
alterations. Microelectrode recordings will provide the spatial trajectory of a seizure and define focus and
penumbra. We will identify region- and cell type-specific alterations by comparing transcriptional profiles across
EEG-characterized samples. We will thereby identify molecules and pathways differentially expressed in seizure
focus vs. penumbra, highlighting processes likely to be primary to seizure generation. In AIM 2 we will perform
immunohistochemical analyses of top target molecules identified in Aim 1, as well as molecules previously
identified to play a role in I/E imbalance in epilepsy and seizure generation. Our studies will thereby provide
microscopic resolution of cellular and subcellular patterns of expression within MRI-guided electrophysiologically
localized biopsies. Illuminating the regional pathophysiology of seizures in intractable focal epilepsy can provide
targets for therapy.

Public health relevance
PROJECT NARRATIVE The mechanisms by which seizures arise and propagate in focal epilepsy remain incompletely understood, particularly how the molecular and cellular alterations in the seizure focus and surrounding brain tissue contribute to this process. We will use single nucleus transcriptional profiling of electrophysiologically-localized brain tissue obtained during epilepsy surgery, allowing identification of genes that are expressed in the seizure focus versus those expressed in regions that resist seizure spread. Our studies will improve understanding of seizure onset and spread in intractable focal epilepsy, providing new targets for treatment in this difficult to treat condition.